Blood Sugar Sensing on Maintenance Dialysis

ABSTRACT
Hyperglycemia is the cardinal manifestation of diabetes mellitus and an established risk factor
for kidney failure, retinopathy, neuropathy, and cardiovascular disease in the general diabetes
population. However, with dialysis, measurement and management of glycemia is notoriously
difficult, due in part to known inaccuracies of hemoglobin A1c. In addition, severe hypoglycemia
is common in dialysis patients with and without diabetes. As a result, relationships of glycemia
with clinical outcomes and unique determinants of glycemia are poorly defined in the dialysis
population. These knowledge gaps preclude development of informed therapeutic strategies.
We initiated the BLOod Sugar Sensing On Maintenance dialysis (BLOSSOM) study to better
characterize glycemia in the dialysis population using continuous glucose monitoring (CGM). In
our initial funding period, we observed high rates of hypoglycemia, but uncontrolled
hyperglycemia was surprisingly predominant. In particular, we observed remarkably poor
glycemic control among dialysis patients with treated diabetes, despite reasonable clinical
hemoglobin A1c measurements, as well as substantial hyperglycemia among participants with
untreated diabetes (who may assume their diabetes is no longer a problem) and among
nondiabetic participants treated with peritoneal dialysis. In this competitive renewal application,
we propose to extend our initial observations to better define the determinants and
consequences of hyperglycemia and hypoglycemia in the dialysis population and advance
appropriate application of CGM in this high-risk group. Specifically, we aim to: (1) test
associations of glycemia, measured by CGM, with long-term clinical outcomes in kidney failure
treated with dialysis by expanding and extending the BLOSSOM cohort and linking with a
comprehensive outcome ascertainment resource; (2) determine the physiologic underpinnings
of the extensive, unanticipated hyperglycemia observed in BLOSSOM by linking frequently-
sampled oral glucose tolerance tests to CGM patterns in a subset of BLOSSOM participants;
and (3) develop novel analytic approaches to improve CGM interpretation and application.
Together, this work will advance understanding of the physiologic basis and health implications
of abnormal glycemia in the dialysis population and provide a foundation for clinical application
of CGM and for clinical trials of new therapeutic strategies.

Public health relevance
NARRATIVE Patients with kidney failure treated by dialysis have high rates of adverse health outcomes, including cardiovascular events, infections, falls, and fractures. High and low blood glucose may be risk factors for these poor outcomes that are modifiable with lifestyle and new pharmacologic interventions. This project will apply state-of-the-art continuous glucose monitoring to dialysis patients to better understand blood glucose patterns and assess whether they are related to relevant health outcomes, filling critical gaps in knowledge that are necessary to design and evaluate new interventions to improve glycemia and related outcomes among people living with kidney failure.